Novel B cell epitope discovery against human coronaviruses

PROJECT SUMMARY
Human coronaviruses have caused devastating global pandemics and epidemics and continue to threaten
global public health. Coronaviruses are highly variable, which has led evasion of most neutralizing antibodies
and reduction in vaccine effectiveness. Many potent antibodies to coronaviruses have very limited breadth, while
some of the broadest neutralizing antibodies described to date exhibit notably lower neutralization potency. Thus,
the exigency to capitalize on what we have learned during the SARS-CoV-2 pandemic to find novel epitopes that
elicit broad and potent antibodies against the coronavirus family and enhance pandemic preparedness.
We have developed a highly integrated platform for identification of B cell epitopes against coronaviruses.
Our previous studies revealed over ten B cell epitopes on the SARS-CoV-2 spike, through comprehensive
characterization and high-resolution structure determination. This project aims to identify novel B cell epitopes
on SARS-CoV-2 and other human coronaviruses, focusing on conserved and cryptic epitopes that elicit broadly
neutralizing antibodies. Specifically, we will (1) identify unexplored epitopes on the SARS-CoV-2 spike protein,
(2) uncover cryptic epitopes that have been largely understudied, and (3) identify pan-sarbecovirus, pan-
betacoronavirus, and pan-coronavirus epitopes. Collectively, utilizing diverse donor samples, state-of-the-art
multi-bait B cell isolation strategies, and high-throughput structural biology, this research aims to uncover novel
B cell epitopes that inform on the design of next-generation vaccines and therapeutics, enhancing our
preparedness for future coronavirus pandemics.

Public health relevance
PROJECT NARRATIVE Human coronaviruses continue to threaten global public health and their high variability enables them to readily escape the immune response. Antibodies to many B cell epitopes of SARS-CoV-2 have now been escaped and antibodies to the few broadly neutralizing epitopes that remain have low potency. This research aims to identify broad and potent neutralizing antibodies that define novel B cell epitopes that are shared on coronaviruses to advance vaccine and therapeutic design and pandemic preparedness against future coronavirus outbreaks.